Understanding Biological and Lifestyle Contributions to Alzheimer's Disease Pathology and Clinical Profiles in Black Women: Defining Prevention Targets in High Risk Groups

PROJECT SUMMARY/ABSTRACT
Women have higher rate of Alzheimer’s disease (AD) and tend to show a more aggressive profile of AD than
men, with greater pathological tau burden and steeper cognitive decline. The prevalence of AD also differs by
race with higher rates among Black versus White older adults. Yet, very little is known about AD in Black
individuals given their historical exclusion in research. Even less is known about the intersection of race and sex
in AD. In this proposal, we aim to study how sex- and/or race-disparate biological (inflammation, insulin
resistance [IR]) pathways and physical activity potentially contribute to tau accumulation and cognitive decline
specifically among older Black women at-risk for AD. We focus on potentially modifiable risk/protective factors
given the recent surge in evidence that modification of these factors can be highly effective in delaying or even
preventing cognitive decline. Our own preliminary work indicated that women may be more susceptible than men
to the adverse effect of inflammation on levels of phosphorylated tau (p-tau) and cognitive function. There is also
evidence that certain lifestyle factors, including physical activity, have a greater impact on AD-related outcomes
such as tau in women versus men. Given links between physical activity and inflammation, we propose to
investigate the interplay between inflammation and physical activity in their contributions to tau and cognitive
decline in older Black women at risk for AD. Since IR is a key driver of inflammation, and the rates of
prediabetes/diabetes are higher in Black adults, we will examine how IR impacts tau accumulation and cognitive
decline. It is critical to examine these relationships in the context of social determinants of health, which are a
driving factor in health outcomes such as inflammation and IR particularly in Black women. To achieve this, we
are conducting a prospective study that will assess all variables of interest and their interactive pathways. The
study will build upon an ongoing pilot study that will collect these variables in 30 White women by study end
(June, 2022), but will represent a more targeted and less invasive study in order to enhance recruitment in the
understudied yet higher risk group of older Black women. We will recruit Black women at two sites, one
leveraging an existing research registry of Black women in Los Angeles, and the other leveraging local
community connections and previous research experience to create a new cohort in San Diego. We will use a
community-based participatory research approach to recruitment that involves decision making at each level
involving a Community Advisory Board. We will measure inflammatory markers in blood, IR, physical activity and
the Area Deprivation Index as our primary social determinant of interest in 100 Black women at-risk for AD and
relate these measures to changes in cognitive function and accumulation of tau, measured in plasma, over a
two-year period. This project will help to close critical gaps in our understanding of risk factors for AD in Black
women by examining biomarkers and social determinants of health in this under-researched yet highly-
vulnerable group. Furthermore, our findings will inform risk reduction strategies that influence these mechanisms.

Public health relevance
PROJECT NARRATIVE Extensive health disparities exist in Alzheimer's disease (AD) and AD research for the Black community in that rates of AD are higher among Black individuals, yet there is a lack of research, and hence understanding, of their experience of this disease. Women show a more aggressive profile of AD than men with higher levels of the Alzheimer's causing pathological tau and a faster rate of clinical decline; inflammation and insulin resistance represent potential mechanisms for these differences given their sex disparities and ties to tau. Through a longitudinal observational study using blood-based markers of inflammation, insulin resistance, pathological tau, and measures of physical activity, we aim to answer the following questions in Black women: 1) How do levels of inflammatory markers and insulin resistance relate to changes in tau deposition and cognitive performance over time? 2) Does physical activity represent a protective factor against tau spread and cognitive decline, possibly through its beneficial effects on inflammation and insulin resistance? 3) How do social determinants of health impact these relationships?